Educating Physician Scientists in Psychiatry (EPSP): Firing up the next generation of translational and clinical neuroscientists

Project Abstract
In this renewal of the Educating Physician Scientists in Psychiatry (EPSP) program at the University of
Pennsylvania (Penn), we aim to build on our successes in intensively recruiting, mentoring, and training
physician scientists in psychiatry (PSPs) beginning early in clinical residency to facilitate rapid, successful career
progression. Penn EPSP will capitalize on the rich scientific environment at Penn to train outstanding and diverse
PSPs. Our goal is to recruit medical graduates with demonstrated research experience and commitment into
careers in psychiatric and neuroscience research. EPSP will be guided by three principles: the centrality of
mentorship to research success, the critical need to recruit the best trainees with attention to diversity, and the
importance of training that is both rigorous and ethical. EPSP provides increasing protected research time during
residency training starting with 10% time in year 1, culminating in 70-80% in the 4th and final year. Simultaneously,
EPSP provides time for formal research education, with intensive focus on research methodologies, career
development, and grant proposal development and writing. Trainees have the opportunity to obtain pilot funding,
providing the ultimate hands-on experience, from research design to data collection, and to analysis and
preparation for publication or presentation. Key EPSP objectives are to intensively mentor PSPs as they embark
on integrated research and clinical training; enhance the diversity of PSPs and the scientific mentors committed
to their development; and prepare PSPs for launching as independent investigators. Importantly, EPSP’s
emphasis on the primacy of mentoring in the success of young physician scientists means that the MPIs will
have significant mentoring time with the trainees to closely monitor progress and track the mentor-mentee
relationship. Innovative hallmarks of the proposed renewed EPSP will include integration of clinical neuroscientist
career development training across Penn Psychiatry and Neurology; strengthened alliances with other Penn
schools/institutions to generate multi-disciplinary research opportunities for trainees; a new Grant Proposal
Success program to maximize competitiveness for NIH K Awards and other extramural research grants;
expansion of PSP pipeline diversity through national recruitment and partnerships with Historically Black
Colleges and Universities; increased availability of diverse mentors; and leveraging the unique demographic
landscape of Philadelphia to create clinical and research experiences for PSPs that reflect the diversity of our
community and those underserved by research and clinical care. Having garnered intensive research experience
under attentive mentoring, trainees will be prepared to tackle the complex scientific challenges facing psychiatry.

Public health relevance
Project Narrative This proposal aims to maintain and expand a residency research training program that recruits medical graduates with demonstrated research experience and prepares them to become independent physician- scientists with careers in psychiatric or neuroscience research, a key NIMH goal. This 4-year program will provide participants with extensive mentorship, formal research training, access to pilot funding, and protected research time. Program trainees will be well-prepared to rapidly progress on the path to NIH K or R awards, accelerating the transition to careers as independent investigators who can address cutting edge psychiatric and neuroscience challenges with public health impact.